Computational Methods Towards the Spatio-Temporal Organization of the Proteome

Project Summary Proteomics and genomics projects have yielded a detailed inventory of proteins in a cell. However, little is known about how these proteins are spatially and temporally arranged within the cell. Such knowledge is essential to understanding how proteins contribute to the structure and function of a living cell. Just as words must be assembled into sentences, paragraphs, and chapters to make sense, vital cellular functions are performed by structured assemblies (or complexes) of proteins rather than individual molecules. Often, these complexes comprise tens or hundreds of proteins. This proposal describes a set of computational methods that will exploit and integrate several kinds of emerging experimental data to uncover the structure and dynamics of protein complexes, toward the ultimate goal of achieving a mechanistic understanding of the cell. In particular, we will characterize proteome organization on two levels through the following projects. (1) We will develop an efficient computational method to determine the structure of individual protein complexes by simultaneously fitting multiple components to cryo-electron microscopy maps. (2) We will develop advanced pattern mining methods to discover and localize unknown protein complexes in whole-cell cryo- electron tomograms - a prerequisite towards comprehensive visual proteomics. We will also develop methods to study the systems dynamics of protein interaction networks within realistic cellular environments. With these tools, we are poised to model the spatial and temporal organizations of proteome. We will freely provide software packages and source code for all methods to the scientific community.

Public health relevance
Project Narrative (Public Health Relevance) Detailed knowledge concerning the spatial and temporal organization of the proteome is essential to understanding how proteins perform their functions in a cell. Proteins need to appear in exactly in the right places at exactly the right times in order to accomplish their roles. Any discrepancies may lead to diseases. In fact, many diseases are known to be caused by malfunctions in proteins or protein interactions. Our proposed methods will significantly contribute to knowledge in this area, so are highly relevant to public health. __SpecificAimsTextDelimiter__ A. Specific Aims Proteomics and genomics projects have yielded a detailed inventory of the proteins in a cell. However, little is known about how these proteins are organized into complexes and how these complexes are spatially and temporally distributed. Such knowledge is essential to understanding how proteins contribute to vital cellular functions. Key elements of the picture are missing at all levels of spatial and dynamic organizations of proteomes: (1) the structures of individual complexes, (2) the spatial distribution of complexes in the cell, and (3) the temporal control of protein distributions and the dynamic interactions between proteins and complexes. Here, we propose a series of computational methods to investigate proteome organization at all these levels. We have the following specific aims: Aim 1. Develop and apply methods for simultaneously fitting multiple assembly components into cryo-EM density maps. Fitting atomic protein structures into cryo electron microscopy (cryo-EM) density maps has proven to be a very effective means of obtaining structural information about macromolecular assemblies. The increasing number of atomic and cryoEM data sets in the public domain has created an urgent demand for efficient and accurate cryo-EM fitting methods. Fitting all components of an assembly simultaneously into a density map is a challenge beyond the scope of almost all existing methods; however, this approach is needed if the researcher lacks prior knowledge about the coarse position of a component and the density maps are of low resolution. Our aim is to develop a novel and efficient mathematical programming algorithm that solves this difficult problem. Aim 2. Develop and apply methods for template-free pattern recognition in Cryo-ET density maps: a step towards visual proteomics. Cryo electron tomography (cryo-ET) enables the 3D visualization of a single cell's interior. Essentially, each whole cell cryo- ET tomogram is a 3D representation of the entire proteome. It therefore represents a snapshot of the interaction networks underlying cellular functions. Retrieving this information is non-trivial due to low resolution and low signal to noise ratio in tomograms. All current pattern recognition methods for cryo-ET focus on matching known structures to the cryo-ET density map. However, so far only a small fraction of all protein complexes have been structurally resolved. We will develop novel, template-free methods for discovering recurrent patterns in molecular density maps, and apply these methods to construct an atlas of the protein complexes in a cell. Through our collaborations with three experimental labs, we will apply our methods to the human pathogen Leptospira interrogans and analyze the distribution of complexes in Herpes Simplex Virion tomograms. Continuing our collaboration with the molecular biologist Shu-ou Shan (Caltech, Co-I of this proposal), we will use these methods also to study the spatial distribution patterns for complexes involved in the translocation of membrane and secretory proteins to the cell membrane in E.coli. Aim 3: Develop and distribute software packages of the methods in Aims 1-2. The two tools described above will facilitate the modeling of the spatial and temporal organization of a full proteome. We will disseminate these tools in form of several stand-alone software packages: (i) a program for simultaneously fitting multiple assembly components into cryo-EM density maps, and (ii) a program for template-free identification of recurrent patterns in cryo-ET maps (to our knowledge, this will be the first software of its kind). These tools will significantly increase the value of the rapidly growing collection of public cryo-electron microscopy and cryo-electron tomography data, and facilitate insights into the spatial and temporal and organization of the proteome within a cell.